Stable and heritable cell-specifc knock down of gene expression in C. elegans

Project Summary The long-term goal of this proposal is to develop a method for stable, heritable and cell-specific knock down of gene expression in the nematode C. elegans. The ability to knock down gene expression in individual cell types in this organism will allow a more detailed understanding of protein function in individual cells and will permit the dissection of cellular interactions such as those present in neural circuits. Our strategy usurps the nonsense-mediated decay (NMD) machinery present in all eukaryotic cells designed to degrade mRNA transcripts that contain premature termination codons. In our strategy we express the gene of interest with a 3'- untranslated region (UTR) that targets the mRNA transcript for degradation in wild-type cells but not in cells in which the NMD machinery has been compromised by mutation. Using cell-specific promoters we can then convert NMD deficient cells into NMD competent cells to cause cell-specific degradation of mRNA transcripts that contain NMD targeting 3'-UTRs. We will demonstrate the feasibility of this method by 1) knocking down the expression of a multicopy transgene encoding a fluorescent protein and 2) knocking down the expression of an endogenous signaling gene. We will quantify the amount of mRNA and protein in these knock down cells. This strategy can be used to knock down the expression of any gene in any cell in the organism. Because many of the proteins expressed in C. elegans have mammalian orthologs (~40% of all genes) our knock down strategy should lead to a better understanding of protein function in humans that will have far-reaching implications on human health. As one example, understanding how neurotransmitter receptors and their intracellular signaling partners function in specific cell types can lead to better therapies for disease states such as Parkinson's disease, schizophrenia and drug abuse.

Public health relevance
Project Narrative C. elegans has proven to be a valuable genetic model organism for study of important biological processes including neurogenesis and degeneration, developmental programming and cell death. Many of the molecular mechanisms identified in the worm that control and/or mediate these processes are conserved in humans and thus studies in C. elegans have contributed to our understanding of many human pathological conditions. The ability to stably and heritably knock down gene function in individual cells in C. elegans will allow unprecedented insight into the cell-specific function of proteins. The knock down approach described in this proposal can be used to study the function of any protein in any cell type to understand any biological process including those that directly benefit human health such as neurotransmission, muscle function, and cell division.